Imaging and Targeted Auger Radiotherapy of High-Grade Glioma

ABSTRACT
Early detection of Alzheimer’s disease (AD) remains a critical unmet clinical need. Poly(ADP-ribose) polymerase-
1 (PARP-1) is a DNA repair enzyme that regulates the expression of pro-inflammatory factors. Microglia, the
primary inflammatory cells of the brain, are intimately associated with amyloid plaques in the brains of patients
with AD. It has been shown that the response of microglia to neuroinflammation is mediated by PARP-1 and that
PARP-1 inhibition or knockout in transgenic AD mice has a beneficial effect on cognitive dysfunction, synaptic
damage, and microglial activation. To date, however, there have been no studies that have investigated a
radiolabeled PARP-1 imaging agent for determining PARP-1 expression in AD mice and correlating the imaging
findings with AD pathology. The parent R01 for this Supplement application focuses on the development of
radiolabeled PARP-1 inhibitors that can be used as tracers for non-invasive positron emission tomographic (PET)
imaging of recurrent glioma. Here, we propose that similar inhibitors can be used to non-invasively track
neuroinflammation related to AD pathology. We hypothesize that radiolabeled PARP-1 inhibitors will
demonstrate specific uptake and retention in a mouse model of AD, compared with age-matched controls. Using
in vivo PET imaging as a readout, we further hypothesize that these radiolabeled inhibitors will effectively
measure changes in PARP-1 expression in cohorts of aged AD mice and that PARP-1 levels will correlate with
the extent of disease progression. The aim of the proposal is to correlate the specific binding of a radiolabeled
PARP-1 analog with Aβ plaques in the brains of AD mice. PET imaging data will be supported by, and correlated
with, MR imaging results from an established pipeline of 1H MRI experiments aimed at assessing brain anatomy
and physiology. This application will be led by a quality team of experts specializing in MR imaging (Dr. Joel
Garbow); PET imaging (Dr. Buck Rogers); radioligand development and labeling (Dr. Dong Zhou); A plaque
biology in AD (Dr. John Cirrito), autoradiography (Dr. Jinbin Xu); and focused ultrasound (Dr. Hong Chen). If
successful, our approach will demonstrate the feasibility of non-invasive imaging of PARP-1 as an early marker
of AD and provide the preliminary data for a subsequent R01 application.

Public health relevance
NARRATIVE The goals of this application are to demonstrate that PARP-1, a DNA repair enzyme that regulates the expression of pro-inflammatory factors, is upregulated in Alzheimer’s disease (AD) and that PARP-1 can be imaged non- invasively using PET in a mouse model of AD. We expect that a PET tracer that binds specifically to PARP-1 will be correlated with levels of A plaques in these mice. PET imaging results will be further supported and validated by MRI. Successful completion of these experiments will establish PARP-1 as an imaging target for the early detection of AD.